PROFESSIONAL SUPPORT FOR SEER AND CANCER CONTROL AND POPULATION BASED RESEARCH.

The purpose of this call order is to obtain services in the following areas: 1) quality control and improvement of cancer data, 2) development of geospatial systems for visualization and dissemination of cancer data, 3 )statistical activities including development of software, methods and statistical applications for analysis of cancer data